UNC Medical Scientist Training Program

Abstract
The primary mission of the UNC MSTP is to train an outstanding group of students committed to becoming
physician scientists, capable of bridging the gap between science and clinical medicine. We strive to achieve
this goal by recruiting candidates from diverse backgrounds who bring a variety of academic and research
interests. We project a steady state of 96 students (12 new students per year) whose academic and
extracurricular experiences are stellar, including substantial research experience and proven commitment to
service. We plan to appoint MSTP trainees to the T32 during their first two years in the program. We will also
appoint students returning to medical school after completing their PhD who do not hold F30 awards. Through
our UNC MSTP, students will be able to pursue their graduate training in 15 individual departments and 5
curricula representing the Schools of Medicine, Public Health, Pharmacy, and the College of Arts and Sciences.
Our leadership team includes Dr. Toni Darville and Dr. Mohanish Deshmukh, who serve as Co-Directors and
Alison Regan, who is the Assistant Director. Our program emphasizes strong education in clinical medicine that
is well integrated with superb research opportunities not only in biomedical sciences but also in other important
areas of public health. Throughout their training, we promote a framework that compels students to define clinical
implications of their research, and how research affects clinical care. Our program leverages resources from the
UNC Clinical Translational Science Award (CTSA), the Biological and Biomedical Sciences Program (BBSP),
links students with physician scientist role models, and structurally integrates research and clinical work in the
thesis process, and in research-in-progress and clinical case conferences. During the PhD phase of training,
students are engaged in a longitudinal clinical clerkship to maintain clinical skills. Graduating PhD students
participate in the Extra Practice to Transition to Application Phase course to promote clinical confidence upon
returning to medical school. These mechanisms help ensure that our students learn essential skills including
conducting rigorous and reproducible research, oral presentation, and manuscript writing. Critical grant writing
skills are taught through a rigorous F30 bootcamp and mock review sessions. Additionally, we meet extensively
with each student throughout their training to ensure that they have a complete support system for research,
clinical, and career mentorship via peer colleagues and faculty. Finally, we expose them to leadership and
career development opportunities to prepare them for careers as Clinician Scientist leaders. Training outcomes
include receiving a high percentage of honors for clinical rotations, obtaining first author publications,
successfully competing for a variety of awards and independent funding (e.g., F30 awards from the NIH),
completing the dual degree program with the average time of 8.1 years, matching at outstanding academic
medical centers for residency, and continuing on to have impactful careers as physician scientists.

Public health relevance
Project Narrative The quickening pace of scientific discovery demands a new generation of physician-scientists who can understand the languages that are spoken both in the research setting and at the bedside. Our plan is to provide rigorous scientific and clinical training in a safe and inclusive environment to train MD-PhD Physician-Scientists. Using this knowledge, these individuals will be ideally positioned to make significant contributions to and improvements in human health, and thereby become the next generation of leaders in biomedical science.